Targeting Lung Cancer Vulnerabilities

Overall SPORE Summary/Abstract
Targeting Lung Cancer Vulnerabilities. The University of Texas SPORE in Lung Cancer represents a unique
collaboration between the University of Texas Southwestern Medical Center (UTSW) and the University of Texas
MD Anderson Cancer Center (MDACC), both of which have outstanding strengths in lung cancer translational
and clinical research. The overarching goal of the SPORE is to develop new therapeutic paradigms based on
recently identified “vulnerabilities” acquired during lung cancer pathogenesis, including a molecular
understanding of lung cancers in individual patients, and using this information to “personalize” therapy for each
lung cancer patient. Thus, our strategy is to identify lung cancer “therapeutic quartets” which include: 1. a
specific vulnerability; 2. the mechanism of action thus defining therapeutic target(s) for the vulnerability; 3. a
deliverable treatment for the target(s); and 4. tumor molecular biomarkers for the vulnerability predicting specific
therapies for each patient. The UT Lung Cancer SPORE builds on a 20-year productive history, incorporating
recent advances made by our SPORE investigators and the rest of the lung cancer translational research
community in the molecular and mechanistic understanding of tumor autonomous and microenvironment
changes, acquired vulnerabilities, and important immuno-oncology effects. These advances include novel
approaches to identifying and molecularly classifying vulnerabilities in lung cancer metabolomic changes,
cancers immunologically “inert” to PD1/PD-L1 checkpoint blockade, the lung cancer fibrotic stroma
(microenvironment), and tumorigenesis-induced replication stress. Our contributions also include preclinical
human and mouse model systems for testing the different vulnerabilities, as well as large legacy molecular and
clinically annotated preclinical model and clinical specimen datasets. The SPORE is composed of 4 projects,
all of which have Human Endpoints: 1. Targeting metabolic vulnerabilities in lung cancer; 2. Targeting
vulnerabilities in immunologically-inert lung cancer; 3. Targeting vulnerabilities in the fibrotic extracellular matrix
(ECM) of lung cancers; and 4. Therapeutic targeting of oncogene-induced replication stress for tumor cell killing
and anti-tumor immunity in small cell lung cancer (SCLC) (which includes a clinical trial targeting replication
stress combined with immune checkpoint inhibtion. There are three cores: A. Administrative (including patient
advocates); B. Molecular Pathology and Tissue Resources; and C. Data Sciences, as well as strong
Developmental Research and Career Enhancement Programs (DRP, CEP). Our SPORE features leading
lung cancer multi-disciplinary clinical and laboratory scientists, a cadre of experienced patient advocates, and
an outstanding publication record. Moving forward, this SPORE will provide information on newly identified lung
cancer acquired vulnerabilities, biomarkers for personalizing individual patient therapy, and important preclinical
and information to facilitate clinical translation that has the possibility of changing the face of lung cancer therapy.

Public health relevance
Overall Project Narrative Lung cancer is the biggest cancer killer of men and women in the USA today and the research proposed in this SPORE seeks to harness recent advances in the molecular understanding of lung cancer pathogenesis, together with advances in clinically available chemotherapy, targeted therapy, radiation therapy, and immunotherapy, to develop new lung cancer therapies. We propose to attack multiple newly identified key vulnerabilities that lung cancers acquire during their pathogenesis that are present in tumor but not normal cells including metabolic, immunologic, microenvironmental, and replication stress vulnerabilities, and are not targets for currently available therapies. In addition, we are identifying molecular biomarkers that identify which lung cancers would be best treated by each of the new therapies to provide “precision medicine” and, if successful, the research of this SPORE should change the face of lung cancer therapy to provide a substantial beneficial impact on the public health.